Contribution of phytochemicals to gut symbiont colonization and synthesis of immunomodulatory sphingolipids

PROJECT SUMMARY
Symbiotic microbiota make critical contributions to host immune development. During the first few years of
human life, and the first three weeks in mice, the gut microbiota undergoes dramatic transformation, mostly in
response to changes in the host environment. How temporal changes and mutual host-microbiota adaptations
shape mucosal immunity remains elusive; however, the contribution of environmental factors (such as shifts in
diet over the life course) warrants molecular-level investigation of the effects of prebiotics/probiotics.
We have previously shown that the ubiquitous human gut symbiont Bacteroides fragilis can modulate host colonic
natural killer T (NKT) cell development by producing unique sphingolipids (alpha-galactosylceramides, or
BfaGCs). Under our original R01, we characterized human microbiota-associated mice (HMA mice).
Supplementation of phytochemicals to HMA mice suppressed colonic NKT cell levels in their offspring. Of note,
in adult HMA mice, phytochemical supplementation can transiently induce the abundance of B. fragilis, strongly
implying that induction of B. fragilis during pre- and postnatal stages is critical for colonic NKT cell development.
In the current proposal, we will dissect the time course of early development and investigate the impact of
phytochemicals on the complex microbiota and subsequent mucosal immune development in early life. This
study will provide valuable information on the effect of beneficial microbes in pregnancy in response to prebiotic
factors, as well as the impact of supplementation during gestation / lactation on the microbiota and immune
development of offspring.

Public health relevance
PROJECT NARRATIVE The first few years of life are critical for establishment of the human gut microbiota, which make important contributions to the host immune system. We have determined that such a change can be recapitulated during first 3 weeks of life in mice colonized with human microbiota. Diet is a major factor shaping microbiota landscape, and we have shown that plant-derived dietary factors (prebiotic phytochemicals) can increase the abundance of Bacteroides fragilis, a symbiotic bacterium that regulates intestinal immune development. Here we will provide prebiotics during pregnancy and lactation, and then study how the induction of beneficial gut microbiota in the mother can affect immune cell proliferation in her offspring and their susceptibility to inflammatory diseases in later stages of adult life.